Surveillance of Diabetes in Young Adults between 18-45 Years of Age (DiCAYA) - Component B

PROJECT SUMMARY
People with diabetes are at high risk of developing a range of diverse microvascular, macrovascular and
neuropathic complications that are associated with high morbidity and erode their quality of life. Diabetes is
expected to take an increasingly large financial toll in in the United States (U.S.) the future, particularly among
working age adults. Ongoing, timely and efficient surveillance of type 1 and type 2 diabetes diagnosed
among young adults aged 18-45 years is essential to identify health disparities and inform health care systems
and the public health community to identify and prioritize strategies to prevent diabetes and its complications.
The Colorado DiCAYA surveillance team is ideally situated to address the critical challenge of utilizing existing
electronic data sources to generate accurate, timely estimates of the incidence and prevalence of diabetes
among the young adult population by type, age, sex, and race/ethnicity subgroups. In response to RFA-DP-20-
001- Component B, we propose to ascertain the annual prevalence and incidence of diabetes among
adults aged 18-45 years of age in the state of Colorado starting with year 2020 from the following data
sources: 1) electronic health records from the well-established SEARCH network of endocrinology clinics,
community clinics and hospital networks in Colorado; 2) a state-wide, legislatively mandated All Payers Claims
Database that contains over 33 commercial health plans and 100% of Medicaid claims; and 3) the University of
Colorado Health System data warehouse (Health Data Compass). Our simple, yet innovative integrated
surveillance approach will utilize a combination of algorithms, incremental record linkage and targeted chart
review to identify young adults with diabetes, distinguish diabetes type and estimate date of diagnosis. Our
specific aims are: Aim 1: SURVEILLANCE (Prevalence)- To ascertain cases of prevalent diabetes among
young adults age 18-45 years, by age, race/ethnicity and diabetes type; Aim 2: SURVEILLANCE
(Incidence)- To ascertain newly diagnosed diabetes cases in young adults age 18-45 years at diagnosis, by
age, race and diabetes type; Aim 3: EVALUATE PUBLIC HEALTH SURVEILLANCE METHODS - To
evaluate the strengths and challenges of our integrated surveillance approach to determine the burden and
incidence of diabetes among young adults 18-45 years by ascertaining validity, completeness and
representativeness of case ascertainment methods.

Public health relevance
PROJECT NARRATIVE Accurate, timely surveillance approaches are needed in the U.S. to understand the incidence and prevalence of diabetes among young adults that can distinguish by type, and generate estimates by race/ethnicity, age group, sex and geographic regions. Continuous monitoring of the young adult population will identify disproportionately impacted subpopulations and aide in the development of primary, secondary and tertiary diabetes prevention and management strategies.